Reward processing in genetic frontotemporal dementia and mood disorders

ABSTRACT
Frontotemporal dementia (FTD) is a common neurodegenerative cause of an early age-of-onset dementia.
Changes in personality, social, and emotional function characterize the behavioral variant of FTD (bvFTD) and
since there is partial overlap with the symptoms of psychiatric illness patients often receive early diagnoses of
major depressive disorder (MDD) or bipolar illness (BPAD). A delay in receiving the correct diagnosis
negatively impacts the care these patients receive. 10-40% of FTD is inherited, most commonly by autosomal
dominant mutations in one of three genes (MAPT, GRN, and C9orf72). By studying the earliest behavior
changes in individuals who carry one of these FTD mutations we can identify features that distinguish mood
disorders from FTD. Reward processing involves a determination of what an individual finds pleasant and will
pursue or work for. Many of the symptoms in bvFTD reflect a shift in reward processing, including changes in
motivation for food, sex, alcohol, money, and social approval. Patients with bvFTD have been shown to be
particularly insensitive to things that others would find negative or aversive. The proposed research will
compare reward processing in presymptomatic patients with genetic FTD and those with mood disorders. We
will study 60 patients with presymptomatic genetic FTD, 60 gene negative members of the same families, 40
patients with bvFTD, 40 with MDD, 40 with BPAD, and will compare them with 60 healthy controls. The central
hypothesis of this proposal is that reward processing differs in characteristic ways between bvFTD, even in its
early stages, and mood disorders in a way that reflects the vulnerable anatomy of these disorders. In Aim 1 we
will identify differences in reward processing abnormalities that distinguish bvFTD from mood disorders using a
series of laboratory-based paradigms during which we will record patient responses and measure their
autonomic nervous system reactivity to rewarding stimuli. In Aim 2 we will assess the diagnostic accuracy of
the reward measures and classification approach from Aim 1 in separating early bvFTD from mood disorders.
In Aim 3 we will correlate patients' reward task performance with the severity of their mood and behavioral
symptoms and will identify the neuroanatomic correlates through structural and functional imaging. The results
of the proposed research will improve early diagnosis of bvFTD through objective, laboratory based measures,
resulting in better clinical care and facilitation of clinical trials; suggest reward-based targets for symptomatic
therapies and reward-based measures of behavior to apply in FTD animal models. It will also expand the
understanding of reward behaviors and their anatomic correlates in psychiatric illness, allowing for more
targeted therapies.

Public health relevance
PROJECT NARRATIVE Symptoms in behavioral variant frontotemporal dementia (bvFTD) involve emotional and personality changes which frequently lead patients to receive an initial diagnosis of a mood disorder. Behavior changes in bvFTD and mood disorders involve distinctive shifts in the valuation of reward and punishment, though there has been little formal study of reward differences between the disorders. By clarifying the reward abnormalities in minimally symptomatic frontotemporal dementia gene carriers and patients with mood disorders and linking reward behaviors to their underlying neuroanatomy, this research will provide tests that improve diagnostic accuracy of early bvFTD and identify therapeutic targets for both bvFTD and mood disorders.